Bioluminescence and Fluorescence Optical Animal Imager

Project Summary/Abstract
The Perkin Elmer IVIS Spectrum requested is a whole animal optical imager capable of 2D
and 3D fluorescence and bioluminescence imaging. The instrument provides high
throughput (up to 10 mice at a time), high sensitivity (down to single cell detection), and a
physiological platform that keeps the animals anesthetized and warm during imaging. Like
other IVIS instruments, the IVIS Spectrum is calibrated in absolute radiance units, allowing
comparison between samples imaged in different instruments. This instrument will
replace an 18-year-old optical animal imager that is no longer supported by the vendor.
More than 32 laboratories depend on the current instrument, and their research would be
catastrophically affected if the instrument failed. Among those laboratories are the 10 NIH-
funded investigators that are the users in this proposal. Being able to provide these
investigators with the Perkin Elmer IVIS Spectrum animal imager would protect their
current capabilities of bioluminescence and restore the fluorescence imaging capabilities
available in the past. In addition the new instrument has better sensitivity and multimodal
flexibility. The research projects thus enhanced will cover studies of immune system
development and autoimmunity, surveillance of HIV CNS reservoirs, immune therapy of
cancer, anti-tumor drug delivery in mammary and prostate cancer, and therapies for
ischemic stroke and Duschenne’s muscular dystrophy.

Public health relevance
Project Narrative Multiple projects at the U. of Minnesota that study Duschenne’s dystrophy, stroke, immunity, and cancer therapies depend on monitoring longitudinal cell growth and location in living animals. The instrument requested will permit those experiments to continue unimpeded, contributing to the development of efficient therapies for those maladies.